Investigating the emergent dynamics of actin filament branch formation and aging using a multiscale computational approach

PROJECT SUMMARY
Actin-binding proteins (ABPs) direct and meticulously regulate several actin-related cellular processes. Actin-
related protein (Arp)2/3 complex is an ABP that nucleates “daughter” branches from existing “mother” filaments
which push against the plasma membrane to facilitate endocytosis and motility. Dysfunction is implicated in cell
invasion and metastasis in which Arp2/3 complex and branch stabilizers such as cortactin are overexpressed.
In filamentous (F-)actin, the bound nucleotide state and rates of transition between states function as a biological
clock to mark the age of the filament. Like F-actin, the Arp2 and Arp3 subunits of Arp2/3 complex bind ATP which
is necessary for the nucleation of the daughter filament. However, the role of ATP hydrolysis and subsequent
phosphate release in both Arp subunits on the aging and dissociation of actin filament branches is still being
explored. In this work, I propose using novel computer simulations to obtain a mechanistic understanding of
three key processes in the aging of actin branch filaments, focusing on the role of the nucleotide state bound to
Arp2 and Arp3 on branch aging and dissociation.
ATP hydrolysis is important for branch dissociation, but not necessary for branch formation. Differences in the
propensities for ATP hydrolysis in Arp2 and Arp3 based on the protein source, the presence of the daughter and
mother filaments, and Arp2/3 complex activation method indicate that multiple factors may influence hydrolysis
rates. Importantly, the outlined factors consist of large protein complexes which preclude conventional quantum
mechanics/molecular mechanics (QM/MM) methods. I will develop a multiresolution computational framework to
obtain thermodynamics, kinetic, and mechanistic insights into ATP hydrolysis in the Arp2 and Arp3 subunits,
respectively, in the context of the coarse-grained protein environment. I will focus on the role of the mother and
daughter filament in facilitating the rearrangement of key amino acids in the active sites of Arp2 and Arp3.
Phosphate release in Arp3 substantially decreases the mechanical stability of branches under force. The release
process itself is very slow with lifetime estimates ranging from <1 minute to >80 minutes depending on the
source. I will employ novel enhanced sampling methods with all-atom molecular dynamics (MD) simulations to
investigate the kinetics and mechanism of release in Arp2 and Arp3. Differences in amino acids of the exit
channel and backdoor gate of F-actin, Arp2, and Arp3 may influence the relative rates of this process. Finally,
debranching under force will be modeled with MD simulations to obtain a molecular-level understanding of the
mechanism and its dependence on the nucleotide state of Arp2 and Arp3. This is important to understand
because it has direct implications for the fate of the branch and its ability to regenerate. Cortactin will be
incorporated into the model to determine how branch stabilizers may influence the debranching mechanism. The
outcome of this work will provide a cohesive mechanistic understanding of ATP hydrolysis, phosphate release,
and branch dissociation which is critical to evaluate the role of Arp2 and Arp3 in growth and turnover of branches.

Public health relevance
PROJECT NARRATIVE Actin-related protein (Arp)2/3 complex, an actin-binding protein, nucleates branches from pre-existing actin filaments and functions in vital cellular processes such as endocytosis and motility. There is increasing experimental evidence that the nucleotide state bound to the Arp2 and Arp3 subunits of the complex plays an important role in the formation, aging, and dissociation of branches, but a molecular level understanding of several key processes is missing. In this work, multiscale computational investigations will unveil the molecular mechanisms and important factors involved in ATP hydrolysis, phosphate release, and debranching.